COMPOSITE OF DRINKING WATER CARCINOGENS

The specific objectives of this contract are (1) to develop some small fish species as suitable models for carcinogenesis bioassays, and then (2) to test those models with a number of common water contaminants, emphasizing those that are a result of the chlorination of municipal water supplies -- the so-called trihalomethanes.